Quantitative Characterization of Glycopeptide Isomers

Because of the pressing needs to comprehensively understand the biological attributes of glycosylation in
many critical biological functions such as the immune response, cell development, cellular
differentiation/adhesion and host-pathogen interactions, glycoproteomics continues to be a highly dynamic
research area. Aberrant glycosylation for decades has been recognized as the attribute of many mammalian
diseases, including osteoarthritis, cystic fibrosis, and cancer. Moreover, isomeric alterations of glycoproteins
have been observed in diseases such as Alzheimer’s Disease and cancers. Recently, glycans and their isomers
have been reported to be vital to the SARS-CoV-2 viral infection, making them a crucial target for the drug
development of COVID-19. Therefore, reliable, and efficient characterization of glycopeptides and their isomers
is necessary to better understand the attributes of glycosylation in biological and biomedical processes. We are
proposing here four specific aims: Aim 1. To enhance the separation and identification of glycopeptide isomers
using mesoporous graphitized carbon (MGC)-LC-MS and hydrophobicity index of peptides (HIP); Aim 2. To
enhance the quantification of glycopeptide isomers using a 15N metabolic-TMT multiplexing approach and a
parallel reaction monitoring (PRM) method; Aim 3. To enhance the glycopeptide isomeric characterization using
novel derivatization methods; and Aim 4. To enhance automated isomeric glycopeptide data processing by the
development of improved software. The outcome of these aims will provide reliable and efficient glycoproteomic
platforms and algorithms for a better isomeric characterization of glycopeptides which can be employed to
address biomedical issue, thus contributing to the glycoscience community. The innovations of this proposal
originate from the uniqueness of the proposed analytical methods and software. The isomeric separation of
glycopeptides using MGC-LC-MS/MS is a highly innovative method, developed in our lab, permitting efficient
separation of glycopeptide isomers on a 1 cm short column. The retention time normalization of glycans intra
and inter-laboratories has been introduced and demonstrated to be necessary previously through a glucose unit
index (GUI), but not in glycoproteomic analysis. For the first time, we will investigate the retention time
normalization of glycopeptides and glycopeptide isomers using a set of peptides which have known
hydrophobicity factors on different instruments and different laboratories. The combination of 15N stable isotope
labeling of glycopeptides and TMT will double the multiplexing capacity of TMT to 36-plex when studying in vitro
cell line glycoproteomics. Although PRM has been utilized for glycoproteomic profiling, the analysis of isomeric
glycoproteomics is lacking. Thus, this will be the first comprehensive investigation of glycopeptide isomers using
PRM. Moreover, the derivatization methods we proposed are of great innovation. It will be the first time to achieve
2-aminobenzamide (2-AB) labeling on sialic acids of glycopeptides, and the first time to achieve efficient isomeric
separation of sialoglycopeptides on a 15 cm C18 column via a two-step oxidation-reductive amination reaction.
In addition, we have achieved a derivatization of sialylated glycopeptides (DOSG) method that will introduce
mass difference to distinguish α2,3 and α2,6 linked sialoglycopeptides. Consequently, the combination oxidation-
reductive amination and DOSG methods leads to an innovative enrichment method for sialoglycopeptides. The
derivatization of carboxyl groups of sialic acids on glycans and amino acids on peptide backbone neutralizes
additional charges and the addition of quaternary ammonium functionalized molecules provides controllable
positive charges which make the enrichment using strong cation exchange (SCX) possible. This is a novel
method for the efficient enrichment of sialoglycopeptides where sialic acid linkage isomers can be distinguished
at the same time. The deliverables of this proposal are reliable, adaptable, and affordable strategies and
improved software to enhance the isomeric glycopeptide studies by any laboratory interested in defining
comprehensive protein glycosylation using LC-MS/MS. The proposed technologies are expected to enable a
better understanding of the biological attributes of glycoprotein isomers in the development and progression of
diseases.

Public health relevance
The main aim of the proposed research is to develop novel methods to improve glycopeptide enrichment, isomeric separation, identification, and quantification. This will be achieved by (1) the development of a novel mesoporous graphitized carbon liquid chromatography tandem mass spectrometry (MGC-LC-MS/MS) platform in combination with a hydrophobicity index of peptides (HIP) for better separation and identification of glycopeptide isomers; (2) the development of a 15N metabolic labeling + 18-plex tandem mass tag (TMT) method to achieve a 36-plex multiplexing and a PRM isomeric glycopeptide approach for better quantitation of glycopeptide isomers; (3) the development of novel glycopeptide derivatization methods to enhance the isomeric glycopeptides characterization and enrichment; and (4) the development of improved software and algorithms to improve automated characterization of glycopeptide isomers. Together, these proposed works will improve glycopeptide isomeric characterization. The outcomes of this proposal will provide reliable and efficient glycoproteomic platforms and algorithms for a better isomeric characterization of glycopeptides which can be employed to address biomedical issue, thus contributing to the glycoscience community.